Mechanisms and functions of host organelle usurpation by intravacuolar Toxoplasma

SUMMARY
Lipids are transferred between membranes by vesicular and non-vesicular routes. Many microorganisms that
infect mammalian cells subvert the function of these host cellular lipid trafficking pathways to acquire lipids.
Toxoplasma gondii is an obligate intracellular parasite that multiplies in the cytoplasm of mammalian cells within
a self-made membrane-bound compartment – the parasitophorous vacuole (PV). The PV of T. gondii does not
fuse with host organelles. However, we showed that the parasite’s intracellular survival relies on lipids retrieved
from various mammalian organelles. For example, T. gondii scavenges cholesterol and sphingolipids from host
endocytic organelles and Golgi vesicles, respectively, which raises the perplexing question of how T. gondii can
access the lipid content of these organelles without fusion. To address this issue, our first strategy was to analyze
vesicular trafficking pathways in infected mammalian cells. We showed that Toxoplasma intercepts mammalian
Rab vesicles associated with recycling, endocytic and secretory pathways, and sequesters these vesicles into a
network of membranous tubules appended to the PV membrane. Our second approach was to analyze non-
vesicular routes of lipid transfer, specifically Membrane Contact Sites (MCS). By examining the physical
connectivity of mammalian host organelles with the PV membrane, we showed that Toxoplasma attracts host
ER tubules and lipid droplets to the PV, where they are closely apposed to the PV membrane at distances
reminiscent of inter-organelle contacts. Mammalian ER-resident Vesicle-Associated Membrane Proteins (VAP),
components of MCS, are associated with the PV membrane, suggesting the potential exploitation of Lipid
Transfer Proteins by Toxoplasma for lipid acquisition.
Based on these preliminary observations, we propose two models for lipid scavenging by Toxoplasma either
mammalian vesicular or non-vesicular lipid transport pathways. We will assess the steps of these models by
defining the molecular machineries and mechanisms involved in the interception of host vesicular pathways by
T. gondii (Aim 1), the formation of a network of membranous tubules in the PV and its role in mammalian
organelle sequestration (Aim 2) and the acquisition of lipids via non-vesicular transfer from mammalian
organelles closely associated with the PVM, possibly through MCS (Aim 3).
Completing these aims would unravel the complexity of lipid salvage processes mediated by Toxoplasma,
providing mechanistic details and identifying future targets for intervention. Indeed, T. gondii can cause fatal
encephalitis in immunocompromised individuals, and current treatment options for toxoplasmosis are limited.
Furthermore, studying the mechanisms used by Toxoplasma to usurp Rab-mediated vesicle trafficking may yield
valuable insights into how Rab GTPases coordinate membrane transport in mammalian cells. Examining the
potential strategies developed by Toxoplasma to exploit MCS may also provide important information on how
the loss of MCS affect mammalian cellular physiology and organismal function.

Public health relevance
RELEVANCE Lipid trafficking pathways play central roles in cell physiology and in responses to challenges by microorganisms. Some intracellular pathogens including Toxoplasma gondii, an opportunistic pathogen in HIV/AIDS patients, subvert these pathways during infection. Our goal is to study the molecular mechanisms employed by Toxoplasma to hijack the vesicular and nonvesicular trafficking in mammalian cells for lipid scavenging and survival.